CHILDHOOD ABSENCE EPILEPSY: RX, PK-PD PHARMACOGENETICS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The major goal of this project is to participate in a multi-center trial to examine the treatment and pharmacokinetic, pharmacodynamic and pharmacogentic aspects of childhood epilepsy.